Peripheral Interfaces in Amputees for Sensorimotor Integration

Veterans who have lost an upper extremity in service of country have lost both hand function and the sense
of touch. Losing these primary sources of physical, manipulative, and emotional connection to the world
results in lifelong functional and social deficits. To restore the emotional and functional aspects of the hand to
a veteran, we have developed an implanted system of nerve electrodes to restore touch and sense of movement
and intramuscular electrodes to provide intuitive, long-term, stable control of prostheses with the look and
functions of a human hand. We have successfully deployed these electrode interfaces in four subjects for more
than six years without significant adverse events. Several case-series studies in-lab demonstrate multiple
important aspects of sensory restoration and prosthesis control. A five-week, in-home case series demonstrated
significant advantages to restoring sensation with even a one degree-of-freedom prosthesis. Beyond the
traditional prostheses, the new system has been connected to an advanced, human hand-like hand that has
sensors at nine locations to be used with the sensory feedback to the user and has individual motion of the
index finger, thumb, wrist, and middle through ring finger as a single group.
The initial trials implemented wires through the skin as connection to the interfaces, but now we have
completed development of a fully-implanted, BluetoothLE™connected system to eliminate these connections.
The next step required to move this new technology towards making the treatment available to veterans is a larger, pilot
randomized clinical trial (RCT) comparing an advanced prosthesis treatment with implanted nerve and muscles interfaces
to traditional, state-of-art, clinically-prescribed prosthesis treatment. The implanted system with sensory feedback
and high degree-of-freedom control is expected to improve the subjects’ outcomes over currently-available
options. The results of this pilot trial will establish the viability and importance of the advanced prostheses and
will support a subsequent pivotal trial.
The study has two aims. Aim 1 will determine the functional outcomes, social outcomes, and usage of an
advanced prostheses with implanted electrodes compared to the subject’s clinically prescribed, state-of-
art prosthesis treatment. Eight subjects will participate in a randomized, 2 x 2 cross-over study comparing
the new human hand-like prosthesis with implanted interfaces to the subject’s commercial prosthesis. Our
primary hypothesis is that within subject differences of the Othortics and Prosthetics User Survey - Quality of
Life (OPUS-QOL) measure will show significant improvement with the advanced prosthesis system. We will
collect weekly surveys for psychosocial outcomes and log device usage when subjects are at home. Subjects
will come to the lab monthly for functional tests and a larger range of surveys to understand the explore the
impact of the prosthesis on the subject’s daily life. Aim 2 will determine if restoration of sensory feedback
alone or multiple degrees-of-freedom alone improves functional outcomes, social outcomes, and usage of
the prosthesis. Following the Aim 1 cross-over study, subjects will continue in a second 2 x 2 cross-over study
comparing sensory feedback with the function of the subject’s commercial prosthesis to no sensory with the
fully functional advanced prosthesis. Our primary hypothesis is that within subject differences of the measures
will show that both sensory feedback and implanted control significantly improve the OPUS-QOL measure
compared to the subject’s clinically prescribed prosthesis treatment, but not as strongly as both together. We
will also collect and analyze the same extensive data set as in Aim 1.
The proposed research will be the first to deploy a prosthetic treatment with a fully-implanted interface in a
long-term, home-use, randomized clinical trial. This is expected to make a significant leap forward toward making
advanced sensory-enabled, intuitive, high degree-of-freedom prosthetic systems available to improve quality of life and
options for veterans with upper limb loss.

Public health relevance
Upper extremity limb loss disproportionately affects veterans compared to the general public. Loss of a limb robs the veteran of both function, and equally important, the sense of touch. The loss of touch comes with significant deficits in quality of life and connection to others. Significant investment over the past decade, however, has resulted in advanced prostheses that have significantly greater function than has ever been available and with a sense of touch such that the user feels the prosthesis as though it is their hand. These advances, however, have only been available in the lab. This project is the first randomized clinical trial to evaluate the if these new prostheses provide a better quality of life compared to prior devices. This project is the next critical step toward making advanced prostheses available as standard of care to veterans and to give them a prosthesis option that effectively replaces their lost hand.